RNA Programmable and Scalable Brain Cell Type Tools Across Vertebrates

ABSTRACT
A major goal in neuroscience is to analyze neural circuit structure and function in diverse brain regions and
species with cell type resolution. Achieving this goal requires novel technologies and reagent resources that
grant cell type access yet are scalable and generalizable across brain regions and species. Transcriptional
regulation of gene expression is a fundamental and universal mechanism underlying cell type specification
across species and life spans. Most current approaches to gain access to cell types attempt to recapitulate
RNA expression patterns through DNA engineering of transcriptional regulatory elements (e.g. enhancers).
However, the generality and scalability of the enhancer approach, especially to other non-model vertebrate
species, remain to be established. We recently invented an orthogonal RNA and translation-based method
that represents a new paradigm in cell type technology. CellREADR/RADARS is built upon the universal RNA
editing system within all metazoan cells mediated by the enzyme adenosine deaminase acting on RNA
(ADAR). CellREADR is deployed as a single modular RNA molecule that detects a specific cellular RNA
through RNA-RNA base pairing and then switches on the translation of effector proteins to monitor and
manipulate the cell. Notably, CellREADR can be delivered efficiently to brain tissues via viral vectors. As
such, CellREADR is potentially highly specific, easy to use, exceptionally scalable and programmable, and
applicable to all vertebrates. Fully realizing the enormous potential of CellREADR requires a scalable and
generalizable platform for systematically screening and validating a large number of RNA sensors for all
major cell types across brain regions and vertebrate species. Here we have assembled an exemplary team
of molecular geneticists, systems and evolutionary neurobiologists, and a physicist to establish a spatial
transcriptomics-based pipeline that is scalable and generalizable for high-throughput screening of RNA
sensor libraries in the brains of different vertebrate taxa. We will first apply this pipeline to identify hundreds
of cell type RNA sensors across marmoset, mouse, songbird, and salamander brain. We will focus on cell
types of the cerebral cortex/pallium, basal ganglia, and thalamus, as these structures give rise to the cortico-
basal ganglia-thalamic circuit loops that are highly conserved across vertebrates and fundamental to sensory,
motor, cognitive, and emotional functions. We will then validate the specificity, efficiency, and functionality of
these RNA sensors. Finally, we will register these sensor libraries with current cell type atlases in each
species and catalog them with validation information in a format that facilitates dissemination through the
BRAIN Armamentarium network and other publicly accessible portals. Our project is poised to transform
vertebrate neuroscience through cell type and circuit resolution comparative analysis and will lay a path to
cell type-targeted gene therapy and circuit modulation in neuropsychiatric diseases.
1

Public health relevance
Narrative We propose to establish a spatial transcriptomics-based pipeline that is scalable and generalizable for high- throughput screen of cell type RNA sensors in vertebrate animals in vivo. We will identify, validate, and catalogue hundreds of cell type RNA sensors across marmoset, mouse, songbird, and salamander brain. Our project is poised to transform vertebrate neuroscience through cell type and circuit resolution comparative analysis, and lay a path to cell type-targeted gene therapy and circuit modulation in neuropsychiatric diseases. 1